Research Training in Endocrinology and Metabolism

PROJECT SUMMARY
This proposed postdoctoral training program (2 fellows/year, 2-year program) in endocrinology and
metabolism will provide comprehensive research training for individuals with a serious commitment to a
career at the interface of biomedical research and endocrine disorders. Metabolic diseases represent
significant health burden in the US; advances in the pathophysiology of these diseases are required to
improve diagnostics, therapeutics and health outcomes. Weill Cornell Medicine (WCM) is experiencing
accelerating growth in clinical and biomedical research activities, due to the singular emphasis on
developing medical research over the past decade during the Deanships of Dr. Laurie Glimcher and Dr.
Augustine Choi. Investment in the Department of Medicine and the Division of Endocrinology, Diabetes
and Metabolism has been significant. Dr. Anthony Hollenberg, a prominent endocrinologist and thyroid
biologist, was recruited to Chair the Department of Medicine in 2018; his support has catapulted metabolic
research to a high priority on campus, resulting in recruitments and significant internal and external
resources. Dr. Laura Alonso, islet biologist and PD on this proposal, was recruited in 2019 to be Chief of
the Endocrinology Division and Director of the Weill Center for Metabolic Health, a newly assembled
research group on campus focused on metabolism, with 45+ faculty and 150+ members. Our proposed
T32 leadership team also includes Dr. Julianne Imperato-McGinley, renowned endocrinologist, prior
Division Chief and current Director of the Weill Cornell CTSC. However, the impetus for this proposal is
not the leadership team, but rather the incredible trainees that have been finding a path to academic
medicine even without T32 support. Three clinical endocrine fellows in the past 10 years managed to
obtain K08 awards and are currently leading successful academic research careers, despite the lack of
an available T32; one of our current 2nd year fellows elected to pursue a 3rd year of research training even
though our program has been advertised as a 2-year clinical program, and both of the incoming clinical
fellows for 2022 are outstanding researchers, one with a PhD from Cal Tech and the other with a first
author Nature Medicine paper in islet biology, mentored by one of our faculty preceptors (Dr. Lo). We
have hand-picked a top team of research Preceptors, and designed a comprehensive didactic training
plan with wrap-around mentoring to guide trainees through eventual R01 submission. Our recruitment
plan is thorough and has a strong emphasis towards enrolling top URM candidates. We propose a tri-
institutional (WCM, MSKCC and RU), rigorous multidisciplinary T32 to enroll 2 postdoctoral MD or PhD
trainees annually for 2 years training duration each. The leaders of this training program will work with
the utmost enthusiasm and energy to ensure that our trainees reach their potential to excel and contribute
significantly to the academic endocrine community for years to come.

Public health relevance
PROJECT NARRATIVE This Research Training in Endocrinology and Metabolism will provide outstanding young physician- scientists and PhD scientists with the resources, skills, knowledge and mentorship they need to launch careers in metabolic research. Providing rigorous, personalized instruction to our amazing trainees will give them a foundation to become successful scientists and leaders in the fields of diabetes, obesity, islet regeneration, thyroid biology and molecular metabolism.